Bayesian Network-Based Integrative Genomics Methods for Precision Medicine

Project Summary/Abstract
Modern multi-platform genomic data sets contain substantial molecular information potentially useful for discovering
new precision therapeutic strategies. Integration across multi-platform data and across genes using network-based
models is a key to extracting mechanistic molecular information embedded in these data. In this proposal, we develop
integrative network-based methods that ll gaps in existing literature. They will be used to identify key pathways for
a given disease and its subtypes, nd key upstream regulators of these pathways and determine which appear to be
causal, construct pathway signatures potentially usable for patient selection, and identify factors modulating pathway
associations. While our methods will be applicable to any disease setting, our initial focus will be to use multi-platform
genomic data sets to provide a deep molecular characterization of four recently discovered consensus molecular subtypes
(CMS) of colorectal cancer (CRC) to arm our biomedical and clinical collaborators with knowledge to devise and test
new precision therapeutic strategies targeting these subtypes. For these purposes, we propose the following aims:
Speci c Aim 1: We will devise a novel model formulation regressing pathway scores on upstream genetic and epigenetic
factors to identify a sparse set of potential pathway drivers. We will identify characteristic pathways for each CMS and
for each pathway identify potential drivers that our biomedical collaborators will functionally validate via CRISPR and
identify potential matching drug targets. We will also develop novel Bayesian hierarchically linked regression models
(BLINK) that will determine which cancers share common pathway drivers and thus are candidates for sharing a common
targeted therapy, while increasing power for discovery of pathway drivers for rare cancers.
Speci c Aim 2: We will develop network mediation analysis approaches to discover putative causal network edges
in multi-layered graphs of multi-platform genomic data. We will use these methods to more deeply characterize the
networks underlying key CMS-characteristic pathways and determine which potential pathway drivers appear to be
causal, and which mediators are predictive of response to therapy. From these networks, we will devise methods to
construct pathway signatures integrating multi-platform molecular information to provide a single-number, patient-
speci c summary of pathway activity potentially useful for patient selection for precision therapeutics.
Speci c Aim 3: We will develop novel Bayesian network regression methods for undirected and multi-layer networks
that identify heterogeneous network structure varying linearly or nonlinearly across patient-speci c covariates. We
will apply these methods to key networks identi ed for CRC data to discover how these networks vary across various
covariates, including subtypes (CMS), biological factors (immune in ltration), and clinical response.
Successful completion of this work will produce a broad set of rigorous tools for integrative and network modeling of
multi-platform genomic data, and will provide our CRC collaborators with a short list of key CMS-speci c pathways and
drivers for functional validation and clinical translation via CMS-based precision therapeutics. Our dissemination eﬀorts
will include software for our methods and Shiny apps for exploring biological underpinnings of CRC.

Public health relevance
Project Narrative Existing large data sets consisting of multi-platform genomic summaries of patient tumors contain rich information that may be useful for personalizing therapy to each individual's cancer, but there is a need for new analytical methods to fully extract the knowledge contained in these data. We will develop new integrative, network-based statistical methods that can uncover mechanistic biological information explaining the speci c characteristics of an individual patients cancer. We will apply these methods to four colorectal cancer data sets to deeply characterize four recently discovered subtypes of this cancer in order to identify new targeted therapeutic strategies that can lead to improved outcomes for colorectal cancer patients.